GH RESPONSE TO OXANDRALONE WITH CONSTITUTIONAL DELAY OF GROWTH IN ADOLESCENCE

To investigate the mechanism of action of testosterone in the treatment of boys with constitutional delay of growth and adolescence. Investigators will compare therapy with testosterone to the therapy of Dehydrotestosterone.